COMMUNITY CLINICAL ONCOLOGY PROGRAM

The Arkansas Oncology Clinic, a two man medical oncology clinic, is applying for this CCOP grant. The Clinic sees approximately 800 new cases of cancer each year. The care of these patients and the general level of care for all cancer patients would be improved by the development of a CCOP in central Arkansas. Multiple modality expertise in surgery, radiotherapy and medical oncology is available in the Little Rock area. It is expected that the goals of the CCOP Program could be carried out by the Arkansas Oncology Clinic.